Investigating Stakeholder Perspectives to Inform Ethical Use of Organoids in Pediatric Rare Disease Research

SUMMARY
Organoids are three-dimensional in vitro structures generated by programming stem cells into organ specific cell
types. These cells self-organize in ways that mimic the structure and function of intact organs, which allows
organoids to act as cellular models for organs in healthy and disease systems. When generated from patient
stem cells, they contain the patient’s DNA and can recapitulate organ-specific disease phenotypes. Organoids
can therefore be used for experimentation such as genetic modification and personalized therapeutic trials
without subjecting patients to physical and medical risks. The parent award, Systematic Identification and
Phenotypic Characterization of Causal Genetic Variants in Rare Disease-Associated Birth Defects, generates
patient-derived brain organoid models of abnormal brain morphology from pediatric patients. These brain
organoids are functionally profiled through single-cell and spatial transcriptomics and may be genetically
modified to functionally characterize candidate causal genetic variants. These organoid studies hold great
promise in identifying causal genetic variants and in characterizing their functional consequences. However,
because organoids are derived from patient tissues they are not seen as morally neutral, with brain organoids
perceived as having special moral value due to the brain’s central role in the concept of self and humanity. While
the use of organoids in biomedical research is advancing quickly, the study of the bioethics of organoid use is in
its infancy. Therefore, the moral and legal status of organoids has yet to be defined and policies and regulations
specific to organoid use have yet to be developed. This supplement aims to provide an evidence-base and
recommendations for policy around organoid use in research by exploring perceptions of organoids and their
use in pediatric rare disease research in key stakeholders. The study will conduct in-depth interviews with 1)
adolescent and young adult patients with diagnosed or suspected rare conditions, 2) parents of child with
diagnosed or suspected rare conditions, 3) researchers actively working with organoids, and 4) bioethicists with
expertise in pediatrics, research ethics, and/or emerging technologies. The patient and parent interviews will
explore perceptions of organoids and imagined connection with various organoid types derived from patient
tissues. They will also explore patient and parent perceived hopes and concerns for organoid use in research
and desired limitations and protections. This data will be integrated into interview guides for researchers and
bioethicists who will be asked not only their own perceived benefits and risks of organoid research, but to
consider the findings from patient and parent interviews to suggest potential solutions that both preserve potential
for organoid research and provide needed protections. The analysis will be reported and used to generate
evidence-based recommendations for policies around organoid use in research.

Public health relevance
NARRATIVE Patient-derived organoids can serve as cellular models of disease and allow experimentation for genetic modification and testing personalized therapeutics without direct medical risk to patients. However, as organoids are derived from human tissues, contain human DNA, and recapitulate phenotypes from the patient from which they were derived, their moral and legal status is unclear. The proposed study will explore attitudes in key stakeholders about the use of patient-derived organoids in research in order to provide an evidence-base for policy.